Project 1 Viral Genomics: surveillance, epidemiology, host response, and viral immunogenicity

Ensuring a world safe from microbial threats remains a pressing challenge. However, significant gaps remain
in our understanding of viral diseases. This proposal employs genomics to address these three major needs:
Genomic detection and epidemiology of emerging viral threats in humans and vectors. For emerging viruses,
such as Lassa, Ebola, Zika, Powassan, and other NIAID Category A-C Priority Pathogens, the natural
prevalence, evolution, genetic diversity, and transmission among and between humans and zoonotic hosts are
not well characterized, which threatens our ability to prepare for and even identify human cases when they
occur. Pathogen genomics provides critical public health insight into the movement of viral threats. In
partnership with established clinical, public health, and academic collaborators in West Africa and
Massachusetts, this project will sequence viruses both human patients and zoonotic reservoirs (African
rodents, American ticks and mosquitoes), publicly distribute genomic and metagenomic datasets, and rapidly
deliver analyses relevant to the evolution, epidemiology and ecology of these viruses, with a focus on insights
that may inform the ongoing development work of diagnostics, therapeutics, and other intervention strategies.
Tissue-specific and single-cell characterizations of host response and viral dynamics during viral hemorrhagic
fever infection. Viral hemorrhagic fevers (VHFs) like Ebola and Lassa are highly fatal, but how the molecular
and cellular host response mechanisms differ between fatal and non-fatal cases is poorly understood. In
partnership with NIAID’s Integrated Research Facility in Frederick, MD (BSL-4), this project will sequence in
vivo VHF infections in animal model organisms, simultaneously profiling both the host transcriptional response
and viral replication and evolution within different host tissues, and utilizing single-cell RNA-seq approaches to
interrogate individual host PBMC types. This will provide a new understanding of cell-specific host response to
VHF infections, with insights into the differing mechanisms behind fatality and recovery and inform the
development of countermeasures for VHFs.
Systematic discovery of viral antigens using thousands of rationally designed oligonucleotides. For most viral
threats, our ability to respond is hampered by a lack of systematic, high-throughput methods that evaluate and
inform the development of therapeutics and vaccines. Although cytotoxic T lymphocytes can afford protection
against a wide range of viral antigens, there has not been a systematic investigation of all possible
immunogenic peptides. Utilizing a “systems virology” approach, we will design, create, evaluate, and test a
large synthetic library of oligos that span large portions of hundreds of human viral pathogens and produce
novel candidate targets for vaccine design.